Admin Core

Project Summary: ADMIN Core
The broad goals of the Administrative Core are to serve as a cohesive unit for the Program Project team in order
to cement their interactions with each other, with the subcontract investigators and the Internal and External
Advisory boards. This Core will see to meticulous financial management of the Program Project; strict adherence
to all University guidelines and research regulations; and to the scheduling of regular meetings of the entire
Program Project to ensure rigor, transparency and reproducibility of the data. Aim 1 will provide supervision of
program finances, administrative and secretarial support, maintenance of authorizations and adherence to
institutional requirements, and coordination of the Subcontracts to the University of Albany and to Columbia
University. Aim 2 will coordinate meetings and videoconferences of the Program Project team, including the
Project Leaders, Core Leaders, all scientific and technical staff at NYU and the University of Albany, and all of
the members of the subcontract teams. Finally, Aim 3 will coordinate meetings of the Internal and External
Advisory Boards for the Program Project. The Administrative Core serves all three Projects and Core 2 over the
five years of the Program Project.